Medical Illness & Cognitive Impairment in Older Adults: Heart Failure as a Model

DESCRIPTION (provided by applicant): The primary objective of this Career Development Award application is to enable the applicant to develop the skills and expertise necessary to become an independent investigator focusing on the important role cognitive function plays in the course of medical illness in older adults. Cognitive impairment (CI) often occurs in the context of chronic medical conditions that are common in older adults and likely influences clinical and quality of life outcomes in these high- risk patients, potentially through impaired self-care. Heart failure (HF) is an ideal condition through which to study the impact of CI on disease self-care and long-term outcomes. The specific aims of my research program are to: (1) prospectively examine cognitive function in patients aged e65 years from the time of hospitalization for HF through 3-months after hospital discharge; (2) prospectively examine the performance of self-care activities from the time of hospitalization for HF through 3-months after hospital discharge; (3) examine the relation between cognitive function and performance of self-care activities at selected time intervals following hospital discharge for HF; (4) develop and pilot test an intervention to enhance self- care practices for HF survivors that is tailored to a patient's cognitive status. A robust training plan will complement this research program and provide the applicant with the tools necessary to be successful as an independent investigator; it will include coursework and focused mentoring in the areas of clinical geriatrics, cardiovascular epidemiology, longitudinal research methodologies, and clinical trial design and implementation. The findings of the work conducted during the award period will have the potential to inform the development of self-care interventions that are tailored to the patient's cognitive status and to improve the health of cognitively impaired patients with chronic medical conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Evidence suggests that cognitively impaired older patients have poor health outcomes including reduced quality of life, repeat hospitalizations, and increased mortality, yet the pathways by which this occurs are not well understood. Understanding the role cognitive impairment plays in patient self-care has significant implications for the design of self-care interventions and for improving the care of older adults with chronic medical conditions. Relevance Evidence suggests that cognitively impaired older patients have poor health outcomes including reduced quality of life, repeat hospitalizations, and increased mortality, yet the pathways by which this occurs are not well understood. Understanding the role cognitive impairment plays in patient self-care has significant implications for the design of self-care interventions and for improving the care of older adults with chronic medical conditions. __SpecificAimsTextDelimiter__ 4. RESEARCH PLAN 4.A. Specific Aims Cognitive impairment (CI) is an increasingly recognized clinical condition in the geriatric population. In older adults, CI is associated with impaired physical function, limitations in activities of daily living, frequent rehospitalization, and premature mortality.35-37 The prevalence of CI increases dramatically with advancing age affecting approximately 10% of persons aged 65-74 years, one quarter of persons aged 75-84 years, and nearly one third of those 85 years and older.38, 39 Because of the aging of the U.S. population, the number of older adults with impaired cognition is expected to more than double over the next 20 years.40 Cognitive impairment often occurs in the context of chronic medical conditions that are common in older adults36 and has been shown to adversely influence clinical and quality of life outcomes in these high-risk patients,41, 42 potentially through impaired self-care practices. Heart failure (HF) is an ideal condition in which to study the impact of CI on self-care and long-term outcomes. Heart failure is a common clinical condition in older adults, occurring in 3-10% of persons 65 years and older, and is associated with considerable morbidity and mortality. Moreover, the number of adults with this clinical condition is expected to double over the next 40 years.43-45 Rehospitalization rates in patients with HF are high with as many as 60% of older patients rehospitalized within 3-months of an acute HF exacerbation.46 Importantly, nearly one half of these readmissions are potentially preventable with optimal medical management and improved self-care practices.47 Self-care of HF is complex and requires patients to monitor symptoms and clinical signs (e.g., weight gain and lower extremity edema), adhere to a number of dietary and lifestyle behaviors, and effectively communicate with their healthcare providers when changes occur; all of these tasks may be more difficult when a patient is cognitively impaired. Present in upwards of one half of older patients with HF,36, 48 CI represents an important, yet underappreciated, condition in this high risk population, the understanding of which will inform the development of interventions to improve self-care practices that are tailored to the patient's cognitive status. In an ongoing prospective cohort study that will eventually enroll more than 1500 men and women hospitalized with HF at 4 medical centers (the NHLBI funded 'Observational Study of HF' RO1 HL077248), measures of cognitive function and patients' self-care practices are currently being assessed during hospitalization for HF and at 1-week, 1-month, and 3 months after discharge. I will build my research program around these measures to examine the relationship between CI and self-care practices. The ultimate goal of my research is to develop an intervention to improve self-care that is tailored to the patient's cognitive status. The primary specific aims of my research program are: 1. To prospectively examine cognitive function in patients aged 65 years and older from the time of hospitalization for HF through 3-months after hospital discharge. 2. To prospectively examine the performance of self-care activities from the time of hospitalization for HF through 3-months after hospital discharge. 3. To examine the relation between cognitive function and performance of self-care activities at selected time intervals following hospital discharge for HF. 4. To develop and pilot test an intervention to enhance self-care practices for HF survivors that is tailored to a patient's cognitive status. In addition, I will examine the relation of cognitive function and self-care on the occurrence of important clinical outcomes including recurrence of HF, rehospitalization, and death in the 12-month period after discharge. This work will lay the foundation for my career as an independent investigator focused on the important role that cognitive function plays in the course of medical illness in older adults. The proposed research and training programs will provide an opportunity to enhance my clinical knowledge base, acquire advanced methodologic skills, and implement an ambitious research program that will lead to RO1-type funding.